L-THREONINE AND BRANCHED CHAIN AMINO ACIDS IN AMYOTROPHIC LATERAL SCLEROSIS

The purpose of this study is to explore, over a six month period, a potenti treatment for ALS, using L-threonine and pyridoxal-5-phosphate or L-leucine L-isoleucine and L-valine versus placebo.